Project 1: Racial and ethnic differences in the intra-tumoral microbiome: Impact on colorectal cancer mortality and clinicopathologic correlates

PROJECT SUMMARY/ABSTRACT of Project 1
Colorectal cancer (CRC) is one of the leading causes of cancer death, and it disproportionately impacts African
American people whose CRC mortality rate is 40% higher than the US average. Given this and the rising rates
of early-onset CRC, particularly among racial and ethnic minority groups, we need new approaches to identify
individuals at higher risk who could benefit from precision screening strategies. Currently, only family history is
used to identify individuals who should undergo earlier and more frequent screening; however, over 80% of CRC
are diagnosed in people without a family history of CRC, suggesting that we need more comprehensive and
tailored ways to stratify individuals according to their risk. Using polygenic risk scores (PRS), which aggregate
all CRC-associated genetic variants into a single score to predict CRC risk, we can identify high risk subgroups
from the general population who are currently considered average-risk but who would likely benefit from targeted
prevention and screening interventions. However, arguably one of the most critical ethical and scientific
challenges related to this is the fact that current PRS are substantially more effective in predicting risk in non-
Hispanic White individuals due to the consequences of the Euro-centric bias present in genetic research. A
promising strategy to address this is the use of functional genomic data to guide PRS development, which we
propose in Aim 1. We will derive functional genomic scores from single cell data for chromatin accessibility and
gene-expression for each cell type and state relevant to CRC (Aim 1a). In Aim 1b we will use machine learning
methods to incorporate the functional genomic scores to build and validate PRS based on data from the largest
and most racially and ethnically diverse genetic epidemiologic consortium (123,000 CRC cases and 228,000
controls, including 45,000 cases and 121,000 controls who do not identify as non-Hispanic White). As an increasing
number of companies are offering PRS direct to consumers, we urgently need to evaluate the clinical value of
PRS for risk stratified CRC screening. Therefore, we will use the microsimulation model MISCAN to quantify the
distributional cost-effectiveness of PRS for risk stratification and estimate the optimal screening strategy in terms
of equity and efficiency based on the PRS across a racially and ethnically diverse population (Aim 2). Our team
is ideally positioned to lead this effort given we discovered most of the common genetic risk factors for CRC,
have a strong track record conducting single cell multi-omic data analyses, developed comprehensive risk
prediction models using cutting edge machine learning approaches, and have a successful history of working
with community advisors. To promote the translation of a novel PRS that performs well across different racial
and ethnic groups, we deliberately focus on increasing diversity in genetic studies of CRC and will make data
and our models publicly available. As PRS are increasingly entering clinical care, our findings will address key
cancer disparities as we seek to improve CRC prevention by guiding personalizing interventions that will reduce
the burden of CRC across racial and ethnic groups.

Public health relevance
PROJECT NARRATIVE of Project 1 The better performance of current polygenic risk scores (PRS) in individuals of European ancestry compared to other genetic ancestral groups creates a major challenge with respect to their broad clinical dissemination, as these PRS have the potential to increase existing differences in colorectal cancer (CRC) rate. We will use a novel strategy that leverages single-cell multi-omic data to develop and validate a PRS that predicts CRC risk across different ancestral groups. We will also evaluate the cost-effectiveness of our PRS and estimate optimal screening strategies in terms of balanced access and efficiency for different risk groups that account for differences in CRC incidence, mortality, and risk factor profiles across different genetic ancestral groups.